Pilot and Feasibility Core

PILOT & FEASIBILITY CORE- ABSTRACT/PROJECT SUMMARY
The Frontiers in Congenital Disorders of Glycosylation Consortium's (FCGDC's) Pilot and Feasibility Core
employs a dual pronged strategy for improving CDG patient care. On one hand, the core will recognize and
fund cutting-edge CDG-focused research proposed by investigators that are new to the CDG field. The goal for
this is to provide them with support (patients, samples, technical resources and funds) to generate preliminary
data for a federal application. This will allow us to train and maintain a vibrant scientific and clinical workforce
which is focused on improving CDG patient care. In parallel, we recognize that CDG is a rare disease and
working in isolation (i.e. without patient or clinical context) may not yield clinically useful results. Hence, we will
also develop a national level CDG-focused annual symposium that will bring together patients, CDG clinicians,
CDG scientific experts and FCDGC pilot and feasibility awardees. The goal for this is to provide a singular
platform where patient issues are discussed and morphed into sound research studies whose results could
improve CDG patient care. We believe that implementing both of the above strategies will not only ensure a
vibrant clinical and scientific workforce focused on CDG patient care but also accelerate the research findings
into practical clinical care solutions for CDG patients.